Long Term Aerobic Exercise to Slow Progression in Parkinson's Disease

Parkinson's disease (PD) culminates in dementia, immobility, and death at a huge societal cost. Even early in
the course, motor and cognitive dysfunction impairs instrumental activities of daily living (IADL). Non-motor
symptoms due to fatigue, mood, sleep, and autonomic disorders further reduce quality of life (QoL). DTI shows
progressive decline in brain tissue integrity. Usual care of PD centers on medical and surgical treatments
relieve motor symptoms, but these cause side effects and lose efficacy over time. Usual treatment for non-
motor manifestations with pharmaceuticals (e.g., antidepressants) is symptomatic and not specific for PD.
Acetylcholine esterase inhibitors exert modest symptomatic benefits on dementia, but there is no approved
treatment for mild cognitive impairment. Physical Therapy is usually prescribed in later stages when mobility
impairment ensues. There is no approved standard exercise regimen for PD. There is no cure or disease
modifying treatment. Thus, there is a critical need for treatments that provide broad spectrum of benefits and
slow PD. Preliminary research suggests that aerobic exercise has potential to meet this need. However,
aerobic exercise is demanding and carries some risks. It is unknown if aerobic exercise is more beneficial than
usual care in PD in long term due to gaps in our knowledge about the effects of cardiorespiratory fitness (CRF)
on brain tissue integrity, motor function, cognition, IADL, QoL, and disease progression. Limitations of current
studies include short duration, small sample size, lack or inadequacy of controls, lack of outcome measures for
cognition and IADL, and lack of biological markers to measure progression. Our objective in this application is
to fill the translational gap by determining the biological, clinical, and functional effects of long term aerobic
exercise (LTAE) in PD. Our overall hypothesis is that LTAE improves brain tissue integrity and slows
down PD. Our FIRST AIM is to determine the effects of LTAE on clinical features and functional abilities in PD.
Our prior 6-month, uncontrolled trial showed preliminary evidence that aerobic exercise improves aspects of
motor function, cognition, and QoL in PD, but long term outcomes and implication for functional abilities are
unknown. We hypothesize that LTAE will provide sustained improvement in motor function, cognition, and non-
motor symptoms with translation of benefits to QoL and IADL. We will test this with a one-year randomized
controlled trial (RCT) that compares the effects of moderate aerobic exercise vs usual care. We will use driving
as the outcome for IADL. Driving represents an important symbol for independence, and depends on integrity
of cognitive and motor systems. Our SECOND AIM is to determine the mechanism of LTAE effects in PD. CRF
reflects complex improvements in vascular, cardiac, and metabolic health from aerobic exercise. There is
preliminary evidence that higher CRF is associated with better brain health and motor/cognitive function, and
that aerobic exercise improves these outcomes. For example, our preliminary study showed improvement of
microtissue integrity in the striatum and white matter on DTI, but it is unclear how these changes counteract
PD progression over long term. Our hypotheses are: 1) LTAE will improve brain tissue integrity as indexed by
DTI, 2) LTAE effects on motor and cognitive function are mediated by changes in brain tissue integrity on DTI,
and 3) physiological processes leading to improved CRF from AE are critical to the benefits on the brain tissue
integrity and motor/cognitive function. We will test these hypotheses determining the effects of LTAE on CRF
and DTI, and the association between individual differences in training-related changes in motor and cognitive
function, DTI, and CRF. In summary, our proposal leverages our diverse interdisciplinary team, strong
preliminary data and past work, and unique infrastructure to determine if LTAE slows down neurodegeneration
and clinical disability in PD.

Public health relevance
Parkinson's disease (PD) is an incurable brain illness that afflicts more than one million Americans, including many of our aging veterans. PD places an unbearable burden on the individual due to progressive impairment of movement and mental function. As a result, patients lose critical abilities such as driving and can become isolated. Although drugs and surgery help movement problems, their benefits are temporary and may cause side effects. Drugs provide limited and temporary benefit for cognition and do not prevent dementia. Animal and preliminary human studies on aerobic exercise show promising results in helping a broad spectrum of symptoms. However, due to limited and inconsistent research results, the long term effects of aerobic exercise on brain health and clinical features in PD is unknown. We will conduct a clinical trial to test the long term effects of aerobic exercise on the brain tissue, movement, mental functions, and driving in PD. If effective, aerobic exercise can be implemented immediately as a low cost, easily accessible treatment in PD.